Burst firing in neurons that represent visual information in the Drosophila compass network

Abstract
Successful navigation requires that our brains continuously maintain and update a sense of our orientation in
space. This internal sense, called head direction (HD), is computed in dedicated neural circuits found across
diverse organisms. The network mediating this representation is “dynamically stable.” In new environments, rapid
synaptic plasticity between sensory neurons and HD neurons enables the HD representation to be updated by
available sensory cues, so that the animal will know the direction that it is facing based on its view of the current
surroundings. Conversely, the HD network must also be able to stably hold the heading representation even
when environmental cues are sparse, such as when the sun becomes obscured on a cloudy day. Local excitatory
loops in the network support a “bump” of high activity that reinforces the location of the HD representation, while
broad inhibition is required to ensure that only a subset of HD neurons is active at once making the HD
representation unique and stable. In the Drosophila HD network, a class of sensory neurons called ring neurons
have been proposed to play a role in both sensory plasticity and widespread inhibition. Ring neurons form
inhibitory synapses onto all HD neurons and these synapses undergo associative plasticity to link heading angle
with features in the environment, though the synaptic mechanisms mediating this plasticity are not understood.
My preliminary data has revealed that a subset of ring neurons that respond to visual cues fire large voltage
events called “bursts” in addition to sodium spikes. I hypothesize that visual ring neuron bursts and spikes encode
for strong or weak visual inputs, respectively, and that bursts are required for plasticity to link HD representation
to visual cues while spikes are important for global inhibition to stabilize the network. I will address this hypothesis
using cell-specific molecular perturbations, whole-cell patch-clamp electrophysiology, and in vivo voltage or
calcium imaging during the presentation of visual stimuli. This project presents a rare opportunity to gain a
molecular-level understanding of parallel neural codes and its importance in HD network dynamics. This work
will inform how visual input entering the HD network are transformed by ring neuron spikes and bursts. I
anticipate that the mechanism I discover will inform models of how HD networks in invertebrate and vertebrate
systems balance flexibility and stability.

Public health relevance
Narrative Deciphering the precise mechanisms that shape neural circuit dynamics is critical both for understanding healthy brain function and for informing top-down design of therapies for disorders which disrupt cognitive processing. Neural circuits that compute heading, an internal sense of direction, are “dynamically stable”; the circuit must be able to flexibly adapt to new environments so you can tell which way you are facing based on the view of your surroundings while also stably maintaining the neural representation so you can preserve a sense of direction even when features in the environment change. This proposal seeks to better understand the sensory processing mechanisms that shape flexibility and stability in heading circuit in Drosophila, a model that allows for the rare opportunity to directly identify the molecules and signaling mechanisms supporting dynamic circuit function.